Research Education Component

Research Education Component (REC): Project Summary
The long-term objective of the Research Education Component (REC) is the establishment of a cadre of
well-trained, highly motivated junior faculty who will become leaders and mentors in scholarship on frailty
and aging and its translation into strategies to maintain independence, health and robustness for older
adults. The REC accomplishes this objective through five specific aims: 1) It partners with the Leadership
Council of the LAC to identify, attract, and select outstanding junior faculty from a diversity of disciplines
with the interest and potential to become future leaders in scholarship on frailty and aging. 2) It provides the
research infrastructure, salary support and protected time essential to enable the selected trainees to
successfully bridge the critical transition to independent grant funding. 3) It provides mentorship with both
team-based and one-on-one elements so as to promote, benchmark, and assure research progress and
career development. 4) It designs for each supported individual a program of subject-area, basic science,
methodological and leadership training to equip him/her for their career goals, and promotes its successful
completion. 5) It creates a welcoming academic home and `stimulus zone' for junior faculty, postdoctoral
fellows, and predoctoral students invested in frailty-related scholarship through a variety of forums for
ongoing networking and intellectual enrichment in which they can interact with each other together with
senior OAIC leaders and faculty. Forums provided complement structured mentorship plans for supported
faculty and include monthly sessions in which REC-, PESC- and DP-supported faculty present research-in-
progress, twice-monthly meetings of the Frailty and Multisystem Dysregulation research working group, and
sponsorship of other working group meetings, seminars and guest lectures in collaboration with partnering
institutional resources on aging. REC-supported faculty receive full mentorial and material support from
each resource core, as appropriate to their interests and needs. A new Information Dissemination Core
(IDC) provides supported faculty with new, broadened avenues via which to disseminate their findings.
Resources are prioritized, first, to K-eligible individuals, followed by R-eligible individuals and then to other
trainees so as to direct Core efforts to provide support at a key transitional point, when research careers are
often in jeopardy because of lack of funding and research infrastructure. The leadership of this Core and the
OAIC as a whole will continue to emphasize training across disciplines and that bridges basic science and
clinical investigation. The overall approach we propose has achieved notable success as evidenced by the
accomplishments and success in receipt of career development awards of previously supported faculty.